Functional and Structural Analysis of the Dot/Icm Type IVB Secretion Machine

PROJECT SUMMARY/ABSTRACT
Legionella pneumophila and Coxiella burnetii are intracellular bacterial pathogens capable of causing human
disease. A notable feature of these two pathogens is that they retain a common virulence determinant that is
essential for their ability to replicate intracellularly, which is the specialized type IV secretion system (T4SS)
called Dot/Icm. The Dot/Icm is an incredibly versatile secretion apparatus that has the capacity to translocate
into host cells a repertoire of over 300 different proteins with different biochemical functions and diverse structural
properties. The goal of this project is to determine the structure and assembly of the Dot/Icm machine and
elucidate how the individual Dot and Icm proteins contribute to machine function at the molecular level. We will
combine advanced cryo-electron tomography (cryo-ET) with genetic and biochemical approaches to determine
the pathway of Dot/Icm machine assembly (Aim 1) and to determine the mechanism by which cytosolic ATPases
recruit effectors and mediate changes in the Dot/Icm structure (Aim 2). Furthermore, we aim to characterize the
translocation pore in the host cell membrane that serves as the protein-conducting channel for Dot/Icm effectors
(Aim 3).

Public health relevance
Project Narrative/Relevance The Dot/Icm type IV secretion system is a versatile virulence nanomachine that has the amazing capacity to translocate into host cells a repertoire of over 300 different bacterial proteins during infection. The proposed work promises to provide mechanistic insights into structure and function of this fascinating nanomachine in intracellular bacterial pathogens: Legionella pneumophila and Coxiella burnetii.